Flavivirus RNA replication proteins: novel targets for drug discovery

Dengue virus and West Nile virus are mosquito-borne flaviviruses with considerable potential as agents for bioterrorism. These positive-strand RNA viruses are also emerging pathogens involved in natural disease outbreaks, making their control a significant public health goal worldwide (especially dengue virus). In addition to vaccine development and anti-viral therapeutics aimed at viral structural proteins, there is a need to identify steps in the intracellular replication cycles of these flaviviruses that can be targeted by small molecule inhibitors. One such step is the replication of viral RNA, a process mediated by the viral RNAdependent RNA polymerase (NSs), most likely in conjunction with other non-structural viral proteins and host cell proteins. Thus, the assembly of viral RNA replication complexes provides unique protein-protein interfaces that once identified, can be utilized as targets for anti-viral therapeutics. The experiments outlined in this proposal involve novel approaches to study dengue virus and West Nile virus RNA replication dynamics in vitro, using a recently-developed high-resolution single molecule bio-detection technology that is based on alternating laser excitation (ALEX) fluorescence spectroscopy. This innovative technology will subsequently be implemented in assays to screen for small molecule inhibitors of flavivirus RNA synthesis. The proposed project will (i) develop a 3-color Excitation/4-color Emission (3cEx/4cEm) ALEX instrument prototype for analysis of single molecule dynamics;(ii) develop reagents and experimental approaches for in uifro flavivirus RNA replication studies using cytoplasmic extracts from mammalian and insect cells;(iii) identify novel anti-viral agents as specific inhibitors of flavivirus RNA replication. Overall, the highresolution power to monitor molecular interactions and flavivirus RNA replication dynamics using the proposed analytical methods and in vitro assays will greatly aid SAR (structure-activity relationship) studies for lead optimization using structure-guided rational drug design.

Public health relevance
The project outlined in this application will develop novel methodologies to understand the intracellular replication mechanisms of dengue virus and West Nile virus, two flaviviruses that are involved in natural disease outbreaks and have considerable potential as agents for bioterrorism. Once elucidated, specific steps in the dengue virus and West Nile virus replication cycles will provide new targets for anti-viral drug design. The innovative analytical approaches generated by the proposed studies will then be used to screen for small molecules that inhibit the growth of these viruses, thereby paving the way for new therapeutics targeting dengue virus and West Nile virus.